Community Outreach and Engagement

COMMUNITY OUTREACH AND ENGAGEMENT
ABSTRACT
Cancer is the second leading cause of death in Utah, and Huntsman Cancer Institute (HCI) is the official
Cancer Center of the State of Utah, pursuant to a 2005 legislative resolution. In recognition of this charge and
the fact that >80% of HCI’s cancer patient population is from Utah, HCI defines its catchment area as the State
of Utah. Further, HCI also serves as the only National Cancer Institute (NCI)-designated Cancer Center in the
vast Mountain West region of the USA that includes Utah, Idaho, Montana, Nevada, and Wyoming.
Through thoughtful monitoring of the cancer landscape in Utah, HCI has identified, invested in, and promoted
research, prevention, and policy measures to address pressing needs of our catchment area, with the goal to
achieve the greatest and most sustainable impact. Three primary focus areas of our efforts include: 1)
Melanoma/Sun Safety: Utah has the highest melanoma incidence in the nation; 2) Lung Cancer/Tobacco
Control/Radon Reduction: Lung cancer is the leading cause of cancer death in Utah; 3) Rural/Frontier and
other Disparity Populations: Major opportunities to address cancer health equity due to Utah's rural/frontier
geography and demographics. In addition, we have invested in areas with opportunities for innovation and
impact based on features of our catchment area: 1) Top Five Cancers in Utah for Incidence or Mortality; 2)
Inherited Cancer Risk; 3) Pediatric/Adolescent Cancers; 4) Prevention of HPV-Related Cancers.
HCI’s Community Outreach and Engagement (COE) efforts encompass two major components. The Center for
HOPE (Health Outcomes and Population Equity) leads our community-engaged and implementation research
efforts to improve cancer-related population health, and the Community Outreach and Prevention Education
office provides outreach and education about cancer risk, prevention, and care to patients and communities
throughout Utah. HCI has an impressive portfolio of catchment-area relevant research, ranging from basic-
science discovery and investigator-initiated clinical trials in our areas of focus, to a recently submitted
Melanoma SPORE, and large team science grants that engage Utah’s Federally Qualified Health Centers.
Finally, COE efforts align with our educational programs to address health equity, which include our CURE
PathMaker Program and GMaP.
HCI also works closely with two major community partners, HCI’s 38-member Community Advisory Board and
the Utah Cancer Action Network, to establish priorities for services, outreach, education, and research.
Through these and other state-wide and broader partnerships, HCI translates science to the community. We
have been successful in achieving and continue to drive policy improvements at local and national levels, with
particular emphasis on cancer-related topics of relevance to Utah.